A novel approach for targeting neuroinflammation in brain aging and Alzheimer's disease

PROJECT SUMMARY
Aging increases the risk for Alzheimer’s disease (AD), but as described in NOT-AG-21-039, the underlying
mechanisms are poorly understood. In this R21 project we propose to test the efficacy of a novel therapeutic
targeting neuroinflammation for protecting against brain aging and AD-related pathology, and to evaluate the
role of the key neuroinflammation mediators NF-κB and NLRP3 in this context. Our rationale is based on pilot
studies we performed using NF-κB/NLRP3-targeted Nanoligomers, a novel class of clinically translatable
small molecules that specifically downregulate gene targets of interest. Our pilot data show that Nanoligomers
targeting NF-κB and NLRP3 have the potential to reduce neuroinflammation, enhance memory (one key
domain of cognitive function that declines with aging and predicts AD risk) and favorably modulate the brain
transcriptome in both aging wild-type mice and a transgenic, AD-relevant mouse model. Based on these
observations, we propose a series of comprehensive pre-clinical studies in which we will test the efficacy of
NF-κB/NLRP3-Nanoligomers for reducing neuroinflammation and protecting different domains of cognitive
function with aging vs. AD-related pathology by administering NF-κB/NLRP3-Nanoligomers to: 1) old wild-type
mice; and 2) transgenic mouse models of both amyloid beta (Aβ) and tau pathology (the main pathological
features of AD). In all models, we will conduct a battery of cognitive-behavioral tests to comprehensively
evaluate the functional effects of NF-κB/NLRP3-Nanoligomer treatment, and we will perform brain region-
specific transcriptomics (RNA-seq) and analyses of numerous neuroinflammation and pathological markers.
We also will perform 3) a series of complementary bioinformatics analyses using existing human datasets to
determine if there is greater evidence of NF-κB/NLRP3-associated neuroinflammation with aging vs. pathology
in the human brain. Together, the results of these experiments will allow us to determine the ideal application
of NF-κB/NLRP3-Nanoligomers (i.e., prevention during aging vs. treatment of pathology), and to establish
evidence for the role of NF-κB/NLRP3-associated neuroinflammation in these specific contexts (an important
question in research on brain aging and AD). Our aims are specifically designed to enable a future R01 project,
as they will provide a basis for larger studies aimed at understanding age- vs. pathology-related
neuroinflammation and insight into how and when to administer Nanoligomers in pilot clinical trials.

Public health relevance
PROJECT NARRATIVE Neuroinflammation (inflammation in the brain) causes reductions in cognitive functions like learning and memory during aging, and it increases the risk for Alzheimer’s disease and other neurodegenerative disorders. The purpose of this research project is to determine if a novel pharmacological treatment that specifically inhibits key cellular drivers of neuroinflammation can improve cognitive function during aging, and/or in the context of Alzheimer’s disease-like pathology. This work may help us understand how and why aging increases the risk for Alzheimer’s disease, and it could provide insight on potential therapeutic strategies for inhibiting these events.